Project 1: Incorporating antibody drug conjugates into mechanism-based combinations to target metastatic breast cancer

PROJECT SUMMARY
The long-term objective of this SPORE project is to identify new, more effective, and less toxic therapeutic
approaches for metastatic triple-negative breast cancer (mTNBC), the most aggressive and poor-prognosis
breast cancer subtype. Our team of DF/HCC investigators and others have led the clinical development of
multiple antibody-drug conjugates (ADCs) for advanced breast cancer, including Sacituzumab govitecan (SG),
achieving improved objective response rates (ORRs), progression-free survival (PFS), and overall survival
(OS) comparted to standard chemotherapy. SG comprises a humanized monoclonal antibody targeting TROP-
2, a tumor antigen expressed in >90% of mTNBC, coupled to the topoisomerase 1 (TOP1) inhibitor SN-38 (the
active metabolite of irinotecan). Despite its benefits, only approximately 30% of patients with mTNBC
experience a therapeutic response to SG, highlighting the unmet need for new approaches to enhance
efficacy. Accordingly, our clinical and translational research program has focused on identifying mechanism-
based therapeutic combinations with ADCs that can overcome de novo and acquired drug resistance. We
recently completed an investigator-initiated phase 1b/2 clinical trial of SG and PARP inhibitor (PARPi,
talazoparib) for mTNBC (NCT04039230), notably delivered via a sequential dosing schedule which we
hypothesized would limit toxicity and improve the therapeutic window. While sequential drug administration
indeed reduced dose-limiting myelosuppression we observed with concurrent dosing, the combination still had
significant hematologic toxicity. In this project, our team of investigators seeks to systematically investigate the
rational therapeutic use of next-generation ADC/PARPi combinations, and to test new ADC combinatorial
therapies. In Aim 1 we will carry out pre-clinical studies leading to design and implementation of a phase 1b/2
clinical trial of a TROP-2 directed, TOP1 inhibitor-based ADC in combination with a novel PARP1-selective
inhibitor, as PARP1 inhibition is known to have a hematopoietic stem/progenitor-sparing effect. We will also
establish the association between therapeutic response and pre-treatment and pharmacodynamic biomarkers
of DNA damage and repair in the context of ADC/PARP1i versus ADC alone through analysis of clinical trial
and other patient samples. In Aim 2 we will systematically test a novel ADC plus targeted therapy
combinatorial approach, revealed through systematic CRISPR screens, that has the potential to enhance
efficacy through dual effects on repair of TOP1-induced damage and expression of TROP2 itself. Collectively,
these studies will implement innovative, mechanism-based clinical trials incorporating ADC-based
combinatorial therapy for patients with mTNBC.

Public health relevance
PROJECT NARRATIVE Use of Antibody Drug Conjugates (ADCs) has yielded substantially improved outcomes for aggressive and poor-prognosis breast cancers, including Triple Negative Breast Cancer (TNBC), but only a minority of patients with advanced TNBC respond to these agents. The co-Leaders of this Project have extensive experience in clinical and translational studies involving ADCs in breast cancer, and are currently focused on developing mechanism-based combinations to overcome ADC resistance. This project proposes to test and identify new targeted therapeutic combinations and associated biomarkers involving TROP-2 directed ADCs in both pre- clinical studies and clinical trials, in order to ultimately improve treatment outcomes for patient with TNBC.